An integrated mathematical modeling approach to define how the aging bone ecosystem drives multiple myeloma evolution and treatment response

Project Summary
Significance: Multiple myeloma (MM) is an incurable bone destroying plasma cell skeletal malignancy with a
peak incidence between ages 65-74 years old. The introduction of therapies such as proteasome inhibitors (PI,
e.g. bortezomib, carfilzomib), and bone protecting bisphosphonates (e.g. zoledronate, ZOL) has vastly
improved patient outcomes. However, MM often relapses, due in part to the protective effects of the bone
ecosystem coupled with clonal evolution. Understanding the interplay between sensitive and resistant clones
and the contribution of the surrounding aging bone ecosystem is critical for enhancing drug efficacy and
emerging adaptive therapy (AT) regimens that we posit could significantly delay patient relapse.
Rationale: Using combined empirical, in vitro, and in vivo data, we generated a hybrid cellular automata (HCA)
mathematical model describing the interactions between PI-naïve and sensitive MM clones and the
surrounding bone ecosystem. In silico, we also simulated the effect of standard of care treatments (PI and/or
ZOL) on MM progression and demonstrated the protective effect of the bone ecosystem to treatment and MM
heterogeneity. Our experimental analyses of aged mice also show major differences in the mesenchymal stem
cell (MSC) compartment that could have profound effects on MM progression and therapy response. We have
also recently optimized spatial transcriptomic protocols for examining population changes and transcriptive
states in naïve and MM bearing bones. Based on these data we hypothesize that, an integrated age-scaled
mathematical model of the MM-bone microenvironment can optimize adaptive therapy and delay the
emergence of resistant disease. To test this, we propose three synergistic and independent aims.
Approaches: In Aim 1, data obtained from spatial transcriptomic analysis of young (3 months) and old (24
months) tumor naïve mice will be used to “age” the HCA model. We will also use data from PI-resistant and
naïve MM isogenic cell lines, grown in the presence or absence of MSCs derived from young or aged mice.
These data will be complemented by ex vivo patient data derived from MM patients’ samples and biopsies. In
Aim 2, we will explore the evolution of PI-resistant disease and bone ecosystem effects in the context of PI
and/or microenvironmental targeted treatment in young vs. aged mice. Results will be used to calibrate the
HCA. In Aim 3, optimization algorithms (OAs) will be used to define AT regimens that outperform standard of
care therapy in aged mice, and in “shadow” clinical trials of newly diagnosed Moffitt MM patients (deidentified).
Innovation/Impact: Our innovative studies will generate a novel HCA model that can be used to dissect the
role of the aging bone ecosystem in MM evolution and therapy response. We also anticipate demonstrating
how ATs can optimize standard of care therapies to delay the emergence of resistant disease in an age related
manner. We believe the proposed studies will be highly impactful from a scientific and clinical view point.

Public health relevance
Narrative Clonal heterogeneity and bone microenvironmental/ecosystem factors to contribute multiple myeloma (MM) resistant disease. Here we propose to generate an experimentally driven hybrid cellular automata (HCA) model, that importantly considers the contributions of the aging bone ecosystem to study the evolution of resistant MM cells over time, under control and standard of care treatment. We will leverage the resultant model to optimize Adaptive Therapies (ATs) that we anticipate will, 1) extend the efficacy of standard of care therapy by delaying the emergence of resistant disease in an age relevant manner and, 2) provide rationale for the application of age appropriate AT regimens to MM patients that will ultimately delay time to relapse and thus, significantly extend their overall survival.